Murine cardiac vector-flow imaging with high-frequency 2D row-column CMUT arrays

Project Summary/Abstract
Cardiovascular disease (CVD) accounts for one of every three deaths each year in the U.S. A substantial pro-
portion of patients with cardiovascular disease develop myocardial dysfunction. Imaging tools that permit early
detection of abnormal hemodynamics and/or mechanics provide an opportunity to initiate targeted therapeutics
and diminish the burden of disease. Mice are the most common model organism for translational CVD studies
of the mammalian heart. Ultrasound (US) is now extensively used in small animals to obtain cardiac functional
parameters. However, advanced US intracardiac vector-ﬂow imaging techniques that are gaining traction for hu-
man CVD, such as cardiomyopathies, have yet to translate to preclinical use, thus, limiting the functional cardiac
parameters that can be obtained from mice. The ability to employ US vector-ﬂow methods to simultaneously re-
solve complex, intracardiac blood ﬂow patterns and cardiac mechanics at sub-millisec temporal resolution, prior
to overt structural and functional abnormalities, would add a new preclinical tool to study the interplay between
blood ﬂow, cardiac mechanics and adaptation in CVD mouse models.
The goal of this project is to develop a novel, 30-MHz, 2D CMUT, row-column (RC) high-frequency-ultrasound
array and a plane-wave vector-ﬂow imaging approach capable of sub-ms, full-frame image capture for intracardiac
imaging in mice. Unlike a standard linear array, the 2D CMUT array will allow dynamic, hands-free selection
of the optimal scan plane and the ability to acquire data in orthogonal image planes. In addition, the CMUT
array will allow us to collect data in adjacent planes to provide a 3D view of ﬂow dynamics within the murine
heart. To validate our system and demonstrate the utility for small-animal imaging, we will study intracardiac left
ventricle (LV) blood ﬂow patterns in two highly related mouse strains that nonetheless display divergent responses
(progressive hypertrophy vs. dilatation and failure) to abnormal pressure overload induced by the well-established
model of transverse aortic constriction (TAC). We hypothesize that our vector-ﬂow system will be able to quantify
abnormal left ventricle ﬂow patterns relative to sham control mice and that we will be able to detect ﬂow disruption
prior to changes in traditional functional echo or strain measures. Importantly, we also hypothesize that distinct
ﬂow pattern signatures can be identiﬁed early in the course of disease that will permit discrimination between
hearts that are destined to develop progressive hypertrophy vs. dilation. The ability to detect subtle phenotypic
changes in common mouse models of CVD that are a result of early-stage diseases or therapies may translate
to earlier and more aggressive treatment of patients at highest risk of pressure-overload induced heart failure.

Public health relevance
Project Narrative This project will develop new 30-MHz, high-frequency ultrasound, plane-wave CMUT row-column instrumenta- tion and signal-processing techniques to determine subtle changes in complex intracardiac blood ﬂow patterns in mouse models of cardiovascular disease. Progressive changes to ﬂow characteristics in transverse aortic con- striction mouse models of cardiomyopathy will be analyzed for ﬂow disruption prior to and during the development of left ventricle hypertrophy or dilatation and heart failure.